Identifying novel immune determinants that influence S. aureus biofilm infection using Collaborative Cross (CC) mouse lines

Staphylococcus aureus (S. aureus) is a leading cause of biofilm-associated prosthetic joint infection (PJI) typified
by antibiotic tolerance and evasion of immune-mediated clearance. Our laboratory has extensively utilized a
model of S. aureus PJI in inbred C57BL/6J mice to define immune attributes that promote biofilm persistence.
This includes an abundance of anti-inflammatory granulocytic myeloid-derived suppressor cells (G-MDSCs) that
inhibit monocyte/macrophage proinflammatory activity and neutrophil (PMN) killing of S. aureus through robust
IL-10 production. Despite these advances, genetic diversity is not captured with inbred mouse strains, and it is
well appreciated that genetic variability in humans contributes to heterogeneity in immunity and disease
susceptibility. This is reflected in our studies of patients with PJI, where transcriptional profiles of leukocytes
recovered from infected tissues displayed significant heterogeneity, even when infected with the same bacterial
species. Furthermore, there are wide variations in the numbers of G-MDSCs associated with human PJI tissues.
Therefore, despite their utility, inbred mice are not capable of capturing the diverse array of genetic factors that
impact disease outcome during human PJI. To address this issue, this proposal leverages the Collaborative
Cross (CC), a genetically diverse group of mouse strains representing > 30 million SNPs that were generated
by crossing 5 classical inbred lines with 3 wild-derived inbred strains. The genomes of CC mice are fully
sequenced, allowing genes of interest to be identified by quantitative trait locus (QTL) mapping to assign
genotype-phenotype relationships. Only one report to date has utilized CC strains to examine host genes that
influence S. aureus pathogenesis in a sepsis model, which is highly divergent from biofilm pathology. Therefore,
due to the lack of comprehensive GWAS studies or the use of CC strains in PJI, little is known about host genes
that regulate biofilm growth. We will leverage CC lines in a two-pronged approach to identify the effect of disease-
associated QTLs on PJI outcome and the intrinsic genetic determinants that shape PMN acquisition of anti-
inflammatory G-MDSC-like characteristics. This is expected to uncover novel host genetic factors that impact
PJI pathogenesis, advancing the applicability of our findings to the clinical realm. This proposal will test the
hypothesis that genetic diversity contributes to the regulation of biofilm growth and inflammation, which will be
examined in the following Specific Aims: 1) Explore the genetic determinants that influence host immunity
during PJI using CC mice; and 2) Identify host genetic loci that are critical for PMN acquisition of G-MDSC-like
properties in response to S. aureus biofilm. These studies are expected to inform our long-term goal of targeting
key host regulatory genes in combination with antibiotics to clear PJI without the need for additional surgeries,
reducing the morbidity for patients suffering from these debilitating infections.

Public health relevance
Approximately half of prosthetic joint infections (PJI) are attributed to Staphylococcus aureus biofilm, which are debilitating due to their chronicity and antibiotic tolerance. This work will leverage the genetic diversity of Collaborative Cross (CC) mice to better model the genetic disparities in humans with PJI to identify host genes that are critical for biofilm growth and inflammation. A better understanding of host-derived genetic factors that regulate immune responses during PJI will guide the development of future strategies for the clinical management of these devastating infections.